Specialized Center of Research Excellence on Sex Differences in Autoimmunity

ComponentAutoimmune diseases comprise a large set of disorders that together afflict almost 50 million Americans; four out of five patients with autoimmunity are women. The mission of the Specialized Center of Research Excellence on Sex Differences in Autoimmunity (SCORE-X) is to serve as a national resource in understanding sex as a biological variable in autoimmunity. SCORE-X has three objectives. Objective 1 is to drive innovation and intellectual leadership of sex biased autoimmunity. Human organoids and spatial proteomics will be employed to dissect the newly recognized role of female-specific XIST RNA protein complex in driving autoimmunity. Objective 2 is to enable translational interdisciplinary advance of sex-biased autoimmunity, focusing on the diagnostic and prognostic opportunities from the recent discovery of anti-XIST RNP antibodies in patients with autoimmune diseases. Objective 3 is to enhance collaborative, and research educational opportunities. SCORE-X will create and coordinate research projects, pilot programs, and educational programs to support the SCORE consortium, and broadly disseminate new insights, technologies, and resources developed at SCORE-X. SCORE-X will promote training and education in sex differences in autoimmunity through the establishment of a Pilot grant program for early stage investigators and integrated educational program along the entire training pipeline. The end result will be a national resource for transformative advance in the mechanistic understanding, clinical translation, and educational opportunities for sex differences in autoimmunity.

Public health relevance
Autoimmune diseases affect nearly 50 million Americans, and 80% of the patients are female. A new discovery has identified a single RNA and its protein partners as the major driver of female predominant autoimmune diseases. By creating a specialized center of research excellence to investigate this novel mechanism and its clinical consequences, we will advance the understanding, diagnosis, and treatment of sex differences in autoimmunity.